Dissecting the role and mechanism of EML4-ALK condensates in oncogenic signaling and tumor growth

PROJECT ABSTRACT. Lung cancer is the leading cause of cancer mortality worldwide, with non-small cell lung
cancer (NSCLC) the predominant histologic subtype of lung cancer and lung adenocarcinoma the major subset
of NSCLC. ALK gene rearrangements (e.g., EML4-ALK fusions) are validated targets in NSCLC and current ALK
kinase inhibitors yield impressive responses. Despite this clinical progress drug resistance remains a problem
that limits patient survival. Improved therapeutic strategies are critical to identify to improve clinical outcomes.
We propose an innovative, multidisciplinary, and collaborative project to hopefully improve the survival of NSCLC
patients by defining a new mechanism of oncogenic signaling that we uncovered by studying ALK fusion
oncoproteins. We aim to capitalize on our discovery of membraneless cytoplasmic protein granules
(condensates) as a distinct mechanism of oncogenic kinase signaling in cancer. Our data suggest an emerging
paradigm in which certain ALK fusion oncoproteins, as well as other clinically-relevant oncoprotein kinase fusions
such as RET fusions, form de novo their own phase separated protein-based subcellular compartment devoid
of lipid membranes and utilize higher-order protein assembly as distinguishing principles underlying oncogenic
output. These membraneless cytoplasmic protein granules comprise a mode of oncogenic signaling that is
different from that of native receptor tyrosine kinase (RTK) signaling and oncogenic, mutant forms of other RTKs
such as EGFR, which use classical lipid membrane-based signaling. The pathogenic biomolecular condensates
formed by ALK (and other RTK) fusion oncoproteins locally concentrate the RAS activating complex GRB2/SOS1
and activate RAS in a lipid membrane-independent manner. RTK protein granule formation is critical for
oncogenic RAS/MAPK signaling output in cells. We identified a set of protein granule signaling components and
established structural rules that define ALK protein granule formation. For instance, protein granule formation
requires the adaptor proteins GRB2 and SHC, in addition to the ALK fusion oncoprotein. Our findings reveal
membraneless, higher-order cytoplasmic protein assembly as a distinct subcellular platform for organizing
oncogenic RTK and RAS signaling in cancer. We propose 2 complementary Specific Aims using innovative
methodologies to probe condensate biology to understand the role of phase separation in ALK fusion oncogenic
signaling. We further define the protein architecture of ALK fusion protein granules and identify the key interacting
proteins required for ALK fusion protein granule formation, oncogenic signaling and tumor growth. The proposed
studies will establish a mechanistic understanding of RTK fusion condensate biology to lay a firm foundation for
the future design of mechanism-based therapeutic strategies to interfere with ALK protein granule assembly per
se and that complement conventional ALK-targeted clinical agents, which are ALK kinase inhibitors. This project
will provide insight into this distinct form of oncogenic signaling with a focus on ALK, with broader implications
for the understanding of condensate and RTK fusion biology and the design of differentiated treatment strategies.

Public health relevance
PROJECT NARRATIVE. Precision medicines that specifically target proteins that drive cancer growth are leading to improved responses in many advanced-stage cancer patients. This molecular treatment approach requires a firm understanding of the biological mechanism of cancer development and progression. The studies in this grant proposal focus on the characterization of a new mechanism of oncogenic signaling, focusing on the role of biomolecular condensates in ALK-driven lung cancer, with the overall goal of laying a foundation for developing a new suite of molecular treatments in the future that better control this cancer through improved precision medicine strategies.